Unraveling the Role of p53 in Endothelium Homeostasis after Ionizing Radiation Exposure

Project summary
Radiation therapy is an important component of cancer treatments, yet its usage has been hampered due to side
effects to normal tissue. The current K99/R00 project seeks to investigate the molecular landscape of radiation
induced coronary heart disease (RICHD), a leading cause of morbidity and mortality among cancer survivors.
The complex nature of RICHD necessitates a comprehensive understanding of patient-specific risk factors and
underlying genetic variations. Focusing on the pivotal role of endothelial to mesenchymal transition (EndMT) and
its correlation with variations in p53 signaling due to TP53 mutations, I will utilize human-induced pluripotent
stem cells (iPSCs) from cancer patients with TP53 mutations and transgenic mouse models in the mentored K99
phase. In my first aim, I will utilize 3D vessel-on-a-chip model (VoC) lined with iPSC-derived endothelial cells
and smooth muscle cells from cancer patients with or without TP53 mutations for longitudinal endothelial lineage
tracing analysis with vascular functional assays after exposure to 2 Gy of X-rays radiation. In my second aim, I
will generate a novel endothelial lineage tracing mouse model with TP53 mutations and elucidate the functional
and molecular alterations after exposure to 20 Gy of X-rays radiation on the heart. Both projects employ in-depth
single cell RNA-sequencing (scRNA-seq) analysis to map the gene regulatory networks perturbations across
different cell-types at varied time points post-irradiation. This project will be guided by an advisory committee
constituted of researchers bringing their distinct expertise: Joseph Wu (Precision Medicine), Laura Attardi (TP53
Biology), Sharon Gerecht (Vascular Engineering), Billy Loo (Radiation Oncology), Kristy Red-Horse (Lineage
Tracing), Michael Snyder (Integrative Omics Analysis). The training received under this mentorship will equip me
with invaluable expertise in tissue engineering, lineage tracing and scRNA-seq analysis. Ultimately, this will foster
my transition to the independent phase (R00), where I aim to establish genotype-phenotype correlations for
RICHD in iPSC-derivatives. Functional radiogenomics on vascular cells will provide novel insights and a
roadmap for stratifying TP53 mutations in RICHD offering a significant advancement for cancer patients
undergoing radiation therapy.

Public health relevance
Project Narrative The current project is designed to study radiation-induced coronary heart disease (RICHD), a major concern in cancer survivors receiving radiation therapy. With miniaturized human vessel tissues and novel mouse models, I will map how radiation exposure dysregulates the vascular health over time and correlate molecular changes to specific mutations in TP53 gene. The ultimate goal is to provide insights for the stratification of cancer patients based on their genetic risk for RICHD to improve patient outcomes post-radiation therapy.